Crystallography and Computational Biology Shared Resource

CRYSTALLOGRAPHY AND COMPUTATIONAL BIOSCIENCES SHARED RESOURCE (CCBSR):
PROJECT SUMMARY
The Crystallography and Computational Biosciences Shared Resource (CCBSR) is a highly specialized shared
resource that provides Wake Forest Baptist Comprehensive Cancer Center (WFBCCC) members with access
to expertise, consultation, and state-of-the-art equipment for structural biology experiments and computational
bioscience approaches. Under the continued tripartite co-directorship of Thomas Hollis, PhD, W. Todd
Lowther, PhD, and Freddie Salsbury Jr., PhD, CCBSR was rated “Outstanding” in the last Cancer Center
Support Grant renewal. CCBSR functions as a collaborative model, i.e., the Co-Directors guide the development
of projects with WFBCCC members, through the collection of essential preliminary data for NIH/NCI and other
cancer-focused funding applications. As a project matures and secures extramural funding, graduate students,
postdoctoral fellows, and technicians are added to the project. As such, the Co-Directors typically contribute to
all publications as co-authors and participate as PI or Co-I on most grant applications. The scientific importance
of this resource centers on the need to understand the molecular basis for protein-protein, protein-DNA/RNA,
and protein-ligand/drug interactions, and how dynamics affect these interactions. This information is crucial for
the development of novel small molecule drugs and other therapeutic strategies. Over the current funding cycle,
26 projects (22 with a cancer focus) have used the CCBSR. There are 17 active projects underway, representing
investigators fromthe Cancer Genetics and Metabolism(CGM) Program, the Signaling and Biotechnology (SBT)
Program, and the Neuro-Oncology (NRO) Program. In the current funding period, the CCBSR contributed to 39
publications. The data collected by the CCBSR enabled 13 of these projects to receive new funding: 10
extramurally-funded (including NCI, NIGMS, NIAID, NIDA, DOD and NSF), 1 industry sponsored research
agreement (SRA) for a novel redox-based cancer therapy, and 2 awards from the North Carolina Center for
Biotechnology. The Specific Aims of the next funding period are to: (1) determine the appropriate
crystallography and/or computational approach for the investigation of protein structure and dynamics alone and
in complex with important biomolecules for cancer research; (2) conduct initial crystallization trials or simulations
to generate preliminary data for grant applications; and (3) provide facilities and expertise for funded projects to
determine the structure or dynamics of important biomolecules in cancer research. All aims include the training
of graduate students and postdoctoral fellows. Graduate students participate in multiple NIH-funded T32 training
programs that incorporate training of this SR into their program offerings.